Role of Piezo1 in Mechanical Touch and Nociception

PROJECT SUMMARY
Detection of mechanical stimuli is crucial for organisms' development and survival. Discriminating between an
innocuous mechanical stimulus and noxious mechanical force is vital to avoid tissue damage and resulting pain.
Cutaneous mechanisms of mechanical stimulus detection have received considerable attention, however, the
sensory neuron-specific mechanoreceptors underlying touch and pain are not fully understood. Piezo1 and
Piezo2 ion channels are bona fide mechanotransduction cation channels expressed at various levels and tissues
that comprise the peripheral nervous system, including keratinocytes and sensory neurons. While sensory
neuron expression of Piezo2 is essential for peripheral sensation of tactile stimuli, relatively little is known about
the role of its close relative, Piezo1. Despite early work suggesting dorsal root ganglia (DRG) sensory neurons
display relatively robust Piezo2 expression and comparatively minimal Piezo1 expression, more recent evidence
suggests that Piezo1 is expressed by sensory neurons and it can be mechanically and pharmacologically
activated in these neurons. This suggests sensory neuron Piezo1 may be functionally important for detection of
tactile and mechanical pain by the somatosensory system. Furthermore, while sensory neuron Piezo2 is
implicated in mechanical allodynia, nothing is currently known about the contribution of sensory neuron Piezo1
to the mechanical allodynia or hyperalgesia characteristic of neuropathic or inflammatory pain conditions. In the
experiments outlined in the current proposal, I will use evoked behavioral assays, patch clamp electrophysiology,
and ex vivo skin-nerve recordings to determine the role Piezo1 plays in sensory neuron-mediated
mechanosensation in naïve (non-injury) and pain (injury) contexts by using transgenic mice with sensory neuron
specific deletion of Piezo1. In Aim 1, I will examine the contribution of sensory neuron-specific Piezo1 to
mechanosensation (Aim 1A), to mechanically-evoked peripheral fiber responses (Aim 1B), and to DRG
responses to mechanical stimuli (Aim 1C). Similar approaches will be used in Aim 2 to interrogate the role of
Piezo1 in mechanical hypersensitivity induced by inflammation, using complete Freund's adjuvant, and
peripheral neuropathy induced by spared tibial nerve injury. I will determine whether Piezo1 contributes to injury-
induced mechanical allodynia and hyperalgesia (Aim 2A), and mechanical stimulus-induced sensitization of
peripheral fibers (Aim 2B) and DRG sensory neurons (Aim 3C). These studies will ultimately reveal additional
roles for mechanically-gated channels in tactile stimulus transduction. Overall, the proposed aims will reveal the
contribution of sensory neuron Piezo1 to detection of mechanical stimuli in non-injury and injury conditions,
potentially revealing new avenues for treatment of mechanical pain.

Public health relevance
PROJECT NARRATIVE The sensory neuron-specific mechanisms underlying mechanosensation in normal and pathological states are not well known. Piezo1 is a mechanosensitive cation channel that is a candidate mechanism in sensory neuron- mediated somatosensation. This proposal examines whether sensory neuron Piezo1 ion channels mediate peripheral tactile sensation and mechanical hypersensitivity following peripheral nerve injury.